PREVENTION OF DEEP VENOUS THROMBOSIS IN CORONARY ARTERY BYPASS GRAFT PATIENTS

Study examining the efficacy of using pneumatic boots for patients post-op coronary artery bypass graft in prevention of deep venous thrombosis. CDMAS only.